Molecular Genetics of HSV Reactivation

Project Summary/Abstract
Herpes simplex virus type 1 (HSV-1) establishes a life-long latent infection within peripheral neurons. During
latency the viral genomes are maintained as circular episomes and the lytic genes are silenced. Periodically
the genomes within some of the neurons reactivate resulting in recurrent clinical disease. A major focus of the
proposed research is to determine the viral and cellular factors responsible for regulating HSV-1 latency.
During the past project period three major findings were: 1) the histone H3K27triMe demethylases UTX and
JMJD3 play a major role in removing repressive heterochromatic histone H3K27triMe marks to facilitate
reactivation. In addition we found that while most non-terminally differentiated cells express UTX and JMJD3
constitutively, sensory neurons do not, but these proteins are induced by at least some reactivation stimuli; 2)
we identified 2 previously un-reported long non-coding RNAs (TAL and ATAL) that are antisense to each other
and the 5' end of the LAT. Significantly, existing LAT promoter mutants reduce the levels of all three transcripts
(LAT, TAL and ATAL). In addition, we found that the TAL and ATAL transcripts are differentially expressed in
neurons with only partial overlap with neurons expressing the LAT; 3) we have developed a means to
knockdown viral and cellular genes in sensory neurons in vivo using AAV vectors. By knocking down the LAT
after the establishment of latency we demonstrate that the LAT RNA specifically contributes to reactivation. In
order to extend the last two of these findings, we propose the following aims: SA1: Dissect the functional roles
that the newly identified LAT region ncRNAs TAL and ATAL play in regulating HSV-1 latency and reactivation;
SA2: Characterize the functional roles that the LAT region miRNAs play in regulating HSV-1 phenotypes
attributed to the LAT. Finally, it is becoming clear from the work of our lab and others that HSV latency is more
dynamic that previously appreciated, and that latent gene expression patterns are heterogeneous. This is
highlighted by the finding that the LAT, TAL and ATAL transcripts are expressed in only partially overlapping
populations of cells. Therefore in our final aim SA3, we propose to use single cell RNA-seq analyses to identify
cell type, viral and host gene signatures of HSV-1 latency and reactivation. For all of these aims we will use
well-established mouse and rabbit models of HSV-1 latency and reactivation, but will extend these studies to
include a novel human neuronal model of HSV-1 latency and validate these findings, where possible, to
analyses of latently infected human trigeminal ganglia.
The proposed studies will provide novel insights into the cellular and viral mechanisms regulating
HSV-1 latency, and allow the assignment of specific functions to the lncRNAs and miRNAs transcribed
from the LAT region. These studies will also provide new critical details concerning the basis of
heterogeneity of gene HSV-1 gene expression in different neurons during latency.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Herpes simplex virus (HSV) causes cold sores, genital lesions and other serious disease in humans including encephalitis and blindness. While there are antiviral drugs to treat herpes, they are not completely effective and there is no vaccine or cure. The proposed research aims to study how viral non-coding RNAs and cellular factors control HSV latent infection and could identify new targets for better therapies to treat recurrent herpes.